B7-H3 CAR T cells following initial radiation for children and young adults with diffuse intrinsic pontine glioma

PROJECT SUMMARY: B7-H3 CAR T cells following initial radiation for children and young adults with
diffuse intrinsic pontine glioma
Central nervous system (CNS) tumors cause the most childhood cancer deaths. Diffuse intrinsic pontine glioma
(DIPG) is a universally fatal CNS tumor responsible for the death of ~400 children each year in the US with
hundreds of failed Phase 1 trials unable to advance to Phase 2 because of the lack of preliminary efficacy. Our
team has demonstrated the preclinical efficacy of B7-H3-specific chimeric antigen receptor (CAR) T cells and
translated them to a completed first-in-human clinical trial, BrainChild-03 (BC-03), that found the highest planned
dose level (10x107 cells/dose) to be the maximally tolerated dose (MTD). Patients were eligible to enroll at any
clinical timepoint (e.g. after initial radiation or after progression) with some patients enrolling after multiply
metastatic recurrences, complicated efficacy analyses. Notably, 10 of 21 treated patients enrolled after their
initial radiation (i.e. before progression) and have a median overall survival (OS) of 17 months (versus 11 months
historically) with 5/10 patients still alive. Therefore, we will open BrainChild-05 (BC-05), a Phase 2 clinical trial of
repeatedly intracranially dosed B7-H3 CAR T cells at the confirmed MTD in patients with DIPG following their
initial radiation. We will also develop advanced neuroimaging automated analysis and CSF correlative
biomarkers to create a centralized pipeline that can be leveraged to distinguish treatment response from
treatment failure in future multi-site trials. Our long-term goal is to create a paradigm of effective locoregional
CAR T cell therapy and monitoring for DMG and all pediatric CNS tumors. Our overall objective is to define the
efficacy of B7-H3 CAR T cells for children with DIPG that incorporates correlative studies able to define signals
of therapeutic benefit. Our central hypothesis, building off our phase 1 experience, is that B7-H3 CAR T cells will
extend OS compared to historical controls; advanced neuroimaging assessments will improve the validity,
reproducibility, and biologic understanding of our therapy; and serial CSF biomarker evaluations will identify
markers of treatment response.
Specifically, in AIM 1 we will open BC-05 delivering repeatedly dosed locoregional B7-H3 CAR T cells at the
MTD in patients with DIPG following initial radiation in order to define the efficacy of this therapy. These activities
will be supported end-to-end by our vertically integrated infrastructure that has launched 16 IND-supported
pediatric CAR T trials. In AIM 2, we will define the ability for programmed volumetric and diffusion pontine
measurements to create a more valid, reproducible assessment pipeline and to define changes in response to
cellular therapy. In AIM 3, we will perform quantitative CAR T cell detection, CSF cytokine analyses, and targeted
mass spectrometry on serial patient biospecimens to quantify immunomodulatory proteins and CAR T target
antigens.

Public health relevance
PROJECT NARRATIVE: B7-H3 CAR T cells following initial radiation for children and young adults with diffuse intrinsic pontine glioma Diffuse intrinsic pontine glioma (DIPG) is responsible for the death of ~400 children each year in the United States, and hundreds of clinical trials have failed to extend survival beyond 11 months. Our team previously has shown the preclinical efficacy of B7-H3 CAR T cells, and now also has demonstrated the clinical feasibility, biologic activity, and initial signal of clinical efficacy of B7-H3 CAR T cells repeatedly dosed intracranially to children with DIPG. Our goal is to build from our rare institutional experience to open a Phase 2 clinical trial aimed at defining the efficacy of repeated intracranial B7-H3 CAR T cells at the already established maximally tolerated dose (MTD, 10x107 cells/dose) to children with DIPG and leverage advanced disease monitoring via automated neuro-imaging and targeted mass spectrometry of CSF biospecimens to identify biomarkers of treatment efficacy and tumor evolution.